Core E Invertebrate Models of Aging

CORE E – INVERTEBRATE MODELS OF AGING
PROJECT SUMMARY
The Invertebrate Models of Aging Core (Core E) at the UW Nathan Shock Center develops and offers unique
services to new and established gerontology investigators to address challenges in aging research with simple
eukaryotic model systems and advanced light microscopy. Because of the long lifespans of vertebrates, getting
answers can be costly in terms of both time and money; invertebrate model systems provide a fast and
inexpensive proxy in which to perform discovery research and test hypotheses. We help new and established
gerontologists rapidly generate data for conserved biological processes affecting the aging process by utilizing
yeast and nematodes, simple model organisms with rapid lifecycles and proven track records of identifying
conserved processes affecting aging. In Aim 1, we will extend the capabilities of yeast geroscience research
using a relatively new tool, the aging chemostat, that allows us to generate large numbers of old yeast cells for
subsequent analyses via advanced light microscopy, proteomics, metabolomics, or genomics/gene expression
studies. In Aim 2, we provide similar capacities for C. elegans animals, muscles, or intestines. In conjunction
with our array of WormBots (automated lifespan measuring machines), we can rapidly test specific mutations
or gene knockdowns for effects on aging. We can determine which region of a gene is required for effects on
aging, and when and where a gene is expressed in the tissues of the nematode. Aims 1 and 2 synergize with
our imaging capabilities in Aim 3, which provide the ability to look at phenotypes, gene expression patterns,
and more in live animals and cells over lifespan. These services synergize with the theme of the UW NSC by
allowing rapid testing or validation of hypotheses generated via multi-omic data and analyses by the other
resource cores. The services provided by Core E have historically been both highly utilized and productive in
terms of publications, grants, and training. In our next cycle, we will introduce a partnership to provide a
pipeline between screening in mammalian cells at the OK NSC and testing for aging effects in invertebrate
models in Core E. In addition, we will combine forces with our own cores, with whom we are poised to make
more collaborative, exciting contributions to aging research. We hope and plan to continue to serve the
gerontology community to generate data to understand the fundamental conserved processes likely to be
affecting aging in humans.